Adaptation and Evaluation of a Culturally- and Gender-Relevant Tobacco Cessation among Women in Brazil: An Integrated mHealth Approach

ABSTRACT
The World Health Organization (WHO) Framework Convention on Tobacco Control has
identified the understanding of women and their tobacco-related issues as well as the need for
the development of gender-relevant tobacco control efforts as priorities. However, there is a
paucity of studies addressing the efficacy of gender-relevant tobacco cessation programs,
particularly in low-resource settings (including the U.S.), that take into consideration the
limitations and strengths of a health care system. We developed and established the efficacy of
a theory-based, culturally- and gender-relevant Community Health Worker (CHW) intervention
for low-income Brazilian women that augments the tobacco cessation program offered through
the public health system. This application represents the continuation of our gender-relevant
tobacco control efforts in Brazil by proposing the adaptation of this CHW-delivered tobacco
cessation program to be integrated with mHealth support through mobile devices (App). We are
proposing an integrated CHW-mHealth application that (a) is culturally- and gender-relevant, (b)
is theory-based (Social Cognitive Theory), (c) considers the existing structure of the Brazilian
health care system, and (d) will be adapted based on an efficacious intervention as well as
salient features of other mHealth applications that have been shown to be successful in
engaging users. During the R21 phase, we will make the adaptations and determine feasibility
of a CHW-delivered intervention that is integrated with a mHealth tobacco cessation application
(interactive App for participants and tracking system for CHWs) through formative assessments
among all involved stakeholders, pretesting, and pilot testing of the intervention. In the R33
phase, we will assess the effectiveness of the integrated CHW-mHealth tobacco cessation
intervention through a group randomized trial with towns as the unit of randomization (8 towns,
N=344). The comparison group will be the same as the previous intervention (consisting of a
home visit by a CHW during which the participant is scheduled to attend the tobacco cessation
program at the neighborhood public health clinic) to allow for comparisons. We hypothesize that
at 6-months, women smokers who receive the integrated CHW-mHealth intervention will have
significantly higher 7-day point prevalence abstinence (defined as no cigarettes in the past 7
days) than women smokers in the control condition. Self-report will be verified through
measurement of exhaled carbon monoxide levels among 30% of participants. If shown to be
effective, this approach could be utilized as a model for a population-based intervention in low-
resource settings, including rural and disadvantaged women in the U.S.

Public health relevance
Project Narrative An understanding of women and their tobacco-related issues, as well as the need for the development of gender-relevant tobacco control efforts, have been highlighted as priorities in landmark guiding documents (e.g., WHO Framework Convention on Tobacco Control). We propose to adapt an efficacious culturally- and gender-relevant Community Health Worker (CHW)-led tobacco cessation intervention to be integrated with a mHealth application among low-income Brazilian women that augments the tobacco cessation program offered through the public health system.